IDENTIFICATION OF NEW TYROSINE KINASE ONCOGENES

In order to understand the role of growth factor receptors in neoplasia, the identification of new oncogenes was attempted. A new gene with extensive homology to v-abl, termed arg (Abelson-related gene), was identified in normal human DNA. This new gene was found to be expressed in several human tissues, as well as a variety of tumor cell lines. Thus, based upon nucleotide sequence diversity and identification of a distinct RNA transcript, arg represents a new functional human gene of the tyrosine kinase family. Investigation of the complete coding sequence of arg should provide insight into its possible function.